Administrative Core

The Administrative Core supervises and manages the Center Core Grant for Vision Research at
the University of Houston (UH) that serves Core investigators in the College of Optometry
Departments of Vision Science and Clinical Sciences, and in the College of Engineering
Department of Biomedical Engineering. The Administrative Core oversees, coordinates and
integrates the activities of the four resource/service modules: Instrument Design, Research
Computer Programming, Biostatistics Support and Biological Imaging. Direction of the Core and
its modules is the responsibility of the PI, the Core Executive Committee that the PI chairs, with
additional guidance by two external advisors. The Executive Committee is composed of the
Directors of the four Core Modules, and one additional NEI-funded Core investigator who
represents the Biomedical Engineering faculty. The Core Executive Committee establishes and
oversees guidelines for utilization of Core Modules, including setting priorities for work requests
to the Modules. It reviews Module access and utilization, budget and policy, conflicts and other
issues, to make decisions requiring interpretation or establishment of policy and to plan strategy
for future growth. The Executive Committee formally meets three times a year, once in each
University term. The Fall meeting is open to all Core investigators and the Winter/Spring meeting
includes the full Advisory Committee which, in addition to the Executive Committee, includes
External Advisors who were selected for their wisdom and expertise in science and administration.
The Administrative Core has necessary staff support with dedicated time, drawn from full-time
staff in the College of Optometry. The summer meeting is busiest in years of competing renewals.
Staff support includes a Core Financial Coordinator who provides the full scope of grants
management and monthly budget reports to the Core. An additional staff member arranges
Executive (and Advisory) Committee meetings and other core events, communicate with Core
investigators about requests for purchases, maintenance and repairs, tracks timelines for
maintenance contracts for Core equipment, and monitors compliance requirements for Core
investigators. The Administrative Core is directed by Dr. Laura Frishman (John and Rebecca
Moores Professor), a retinal physiologist with 19 years’ service as the Core PI.